Hawaii's FERN Microbiology Laboratory's Role in Keeping Human Food Products Safe - Part II

Hawaii State Department of Health
State Laboratories Division
Laboratory Preparedness and Response Branch
Biological Response Section
Laboratory Flexible Funding Model (LFFM)
Project Title: Hawaii’ FERN Microbiology Laboratory’s Role in Keeping Human Food Products Safe – Part II
The overarching objective of the proposed projects is to maintain, enhance and strengthen the capacity and
capabilities of Hawaii’s FERN Microbiology laboratory in keeping human food products safe, thereby contributing
to strengthening and improving FDA’s efforts in preventing foodborne illnesses.
To accomplish this objective, we are requesting funding for the following:
Project A1: Microbiology Human Food Product Testing
Hawaii ‘s FERN laboratory aims to build upon the progress made during the first iteration of the LFFM grant (2020-
2025.). Hawaii would like to contribute to the national food testing surveillance program with the aim of removing
potentially contaminated food products out of reach by consumers and aid in inspections and investigations.
Furthermore, our participation in this project would provide us the necessary tools to potentially identify emerging
issues and/or assist in unraveling the source of the foodborne illness.
Project A4: Microbiology Whole Genome Sequencing – Maintenance
Funding for this project will allow us to sequence isolates recovered from CRO’s and isolates from environmental
samples as part of for-cause facility investigations and tracebacks.
Project A6: Microbiology Food Defense
By participating in the food defense project, the HI FERN Microbiology laboratory aims to prepare and respond
to possible intentional microbiological contamination of food products not only in Hawaii but to serve as a surge
laboratory on a national scale.
Project A7: Microbiology Method Development and Method Validation
Funding for this project will provide an opportunity for the Hawaii FERN Microbiology laboratory to participate in
short term investigations on new methodologies/technologies.
Project A8: Microbiology Capacity/Capability Development
Funding for this project will assist our laboratory in implementing new capabilities. By implementing new
capabilities, testing can be done in-state without the need to send samples to the nearest FDA Office which is
five hours away by air.

Public health relevance
Hawaii State Department of Health State Laboratories Division (SLD) Laboratory Preparedness and Response Branch (LPRB) Biological Response Section (BRS) Laboratory Flexible Funding Model (LFFM) Project Title: Hawaii’ FERN Microbiology Laboratory’s Role in Keeping Human Food Products Safe – Part II The overarching objective of the proposed projects is to maintain, enhance and strengthen the capacity and capabilities of Hawaii’s FERN Microbiology laboratory in support of the nation’s objective of building an integrated laboratory science system. By enhancing and strengthening Hawaii’s FERN Microbiology laboratory, it will be able to test more food products using uniform validated national protocols and contribute to the accumulation of food testing data to identify microbial contamination of food products before reaching the consumers. To accomplish this objective, we are requesting funding for the following projects: Project A1: Microbiology Human Food Product Testing Hawaii ‘s FERN laboratory aims to build upon the progress made during the first iteration of the LFFM grant (2020- 2025.). Hawaii would like to contribute to the national food testing surveillance program with the aim of removing potentially contaminated food products out of reach by consumers and aid in inspections and investigations. Furthermore, our participation in this project would provide us the necessary tools to potentially identify emerging issues and/or assist in unraveling the source of the foodborne illness. BRS-LPRB-SLD plans to perform at least 250 analyses selected from FDA’s priority commodity-hazard pairs list (examples: Salmonella, STEC, Listeria, Cyclospora, Norovirus, Hepatitis A). Additionally, SLD will continue its partnership with the US FDA San Francisco District Laboratory and the Division of West Coast Imports (DWCI) Project A4: Microbiology Whole Genome Sequencing – Maintenance The BRS-LPRB-SLD is a member of the PulseNet network – a network of public health and food regulatory agency laboratories that perform molecular testing of foodborne disease-causing bacteria. Since August 2019, BRS-SLD has transitioned from the traditional Pulse Field Gel Electrophoresis (PFGE) to whole genome sequencing (WGS). In 2015, BRS-SLD became a member of the GenomeTrakr Network sharing files of isolates from environmental samples and contaminated food products. We plan to sequence all isolates recovered from CRO’s and isolates from environmental samples as part of for- cause facility investigations and tracebacks. Project A6: Microbiology Food Defense By participating in the food defense project, the HI FERN Microbiology laboratory aims to prepare and respond to possible intentional microbiological contamination of food products not only in Hawaii but to serve as a surge laboratory on a national scale. To ensure our readiness to respond to possible unintentional and intentional microbiological contamination, we will maintain functioning BSL-2 and BSL-3 laboratory facilities, including certification requirements, maintaining staff competency to perform food testing, maintaining necessary equipment for testing that are readily available when needed and ensuring the availability of reagents and supplies. Project A7: Microbiology Method Development and Method Validation Participation for this project will provide an opportunity for the Hawaii FERN Microbiology laboratory to participate in short term investigations on new methodologies/technologies. Project A8: Microbiology Capacity/Capability Development This project will assist our laboratory in implementing new capabilities. Implementing new capabilities will allow us to conduct testing-in-house rather than sending samples to the nearest FDA Office, which is five hours away by air. This will streamline our processes and improve efficiency.